Scale-up and Manufacturing of STLR-201, an off-the-shelf regenerative therapeutic for Sjogren's syndrome-related dry eye disease

PROJECT SUMMARY: Sjogren’s syndrome-related dry eye (SSDE), affects about two million people in the U.S.
and arises from an autoimmune disorder that damages the lacrimal glands. A cascade of pathological changes
perpetuates and advances corneal damage, resulting in pain, blurred vision, and photosensitivity that makes it
difficult to perform daily functions, resulting in reduced work productivity and a greatly reduced quality of life.
Most therapies only temporarily treat symptoms, and the underlying SSDE can continue to progress. In addition,
some treatments are slow to take effect and have side effects, making them less appealing to patients. Several
disease-modifying therapies have shown promise against dry eye disease in general, including autologous blood
products; however, these autologous products are patient-specific, requiring individualized manufacturing that
lacks product characterization or quality control and are not covered by insurance. Therefore, there is a critical
unmet need for an off-the-shelf, fast-acting, disease-modifying SSDE therapy. Stellular Bio has harnessed the
power of platelet and stem cell biology to produce an off-the-shelf SSDE therapeutic. Their proprietary platform
enables the differentiation of induced pluripotent stem cells into platelet precursor megakaryocyte-like cells
(MLCs) to generate an MLC extract containing a unique blend of growth factors and cytokines known to stimulate
corneal epithelial and neuronal cell growth and reduce immune cell-mediated cell loss. This MLC extract, being
iPSC-derived, makes for a quality-controlled, allogeneic, ocular product with a renewable cell source. Stellular
Bio's therapeutic candidate, STLR-201, promotes corneal epithelial cell proliferation in vitro and significantly
improves corneal barrier integrity in dry eye disease mouse models in two weeks, with effects persisting at least
two weeks post-treatment. Thus, STLR-201 represents a promising SSDE therapeutic. This SBIR Fast-Track
project will finalize the STLR-201 drug substance processing strategy and scale up production and GMP manu-
facturing to support chemistry, manufacturing, and control (CMC) and GLP toxicology studies, which will be
accomplished with the following specific aims: Phase I – 1) Finalize drug substance processing strategy and
scale up to enable processing of MLCs from a full-size manufacturing run; 2) Determine comparability of new
pilot process and proof-of-concept product, including in vitro and in vivo bioactivity; Phase II – 1) Process devel-
opment: production of MLCs by stirred bioreactor culture, establishing a scalable, more efficient, cost-effective
manufacturing method; 2) Perform engineering runs of final STLR-201 production process, including variability
testing and generating product for IND-enabling studies; 3) Perform STLR-201 GMP manufacturing run, includ-
ing defining release criteria, generating GMP product, and evaluating stability. Project success will generate an
optimized GMP STLR-201 manufacturing process and critical CMC data to support IND submission and clinical
trials. STLR-201 is poised to be the first FDA-approved off-the-shelf regenerative SSDE treatment that can stop
disease progression and restore cornea integrity, providing life-changing outcomes for SSDE patients.

Public health relevance
PROJECT NARRATIVE: Sjogren’s syndrome-related dry eye affects approximately two million people in the U.S. but lacks adequate treatments. Stellular Bio's STLR-201, being advanced under this Fast-Track project, can rapidly repair underlying SSDE damage to reverse disease progression. This disease-modifying therapeutic will allow patients to return to normal life activities and work productivity.